Biostatistics and Bioinformatics Core (BBC)

Project Summary
Biostatistics and Bioinformatics Core (Shared Resource)
TUFCCC: Eric A. Ross, PhD (Co-Leader) HC: Konstantinos Krampis, PhD (Co-Leader)
The goal of the Biostatistics and Bioinformatics Core (BBC) is to enhance cancer health disparities research in
underserved African-, Asian- and Latinx American communities in Philadelphia, New Jersey and New York City
by providing expertise in experimental design, biostatistics, bioinformatics, genomics, clinical cancer genetics,
mixed methods research, machine learning and artificial intelligence. BBC members were selected based on
their substantial expertise in quantitative science, qualitative research, high performance computing and software
development, laboratory investigations and clinical cancer genetics. Its members provide the capacity to create
innovative methods and systems to address new problems and technologies that surface in a rapidly changing
scientific environment. BBC activities will leverage the collaborations and tools developed during the current
funding cycle to accelerate future, high-quality cancer disparities research throughout the TUFCCC/HC Cancer
Partnership. This highly interactive Core will play fundamental roles in all phases of study design/execution, and all
Partnership projects and cores will interact with the BBC. The specific goals of the Biostatistics and Biostatistics
Core are to: (1) Provide expert consultation in the rigorous design of experiments and studies, including research
proposal development. (2) Support U54-supported research by analyzing study results with appropriate
quantitative, mixed methods, and computing approaches developed in-house or current best practices in the
field. Assist investigators with the interpretation and presentation of results, and the writing of statistical and
bioinformatics components of manuscripts. (3) Develop novel Machine Learning/Artificial Intelligence (ML/AI)
algorithms to facilitate cancer disparities research by enhancing knowledge extraction from multi-omic data
resources. Provide training in the latest ML/AI research tools for cancer applications. (4) Provide expert clinical
cancer genetics advice, and cost-effective, high-throughput genomic and epigenetic services to meet the critical
molecular laboratory needs of the proposed research projects as well as future U54-supported investigations.
Maintain the computational infrastructure for the collection, storage and analysis of data generated by U54-
supported investigations. By providing diverse expertise, and informatics and laboratory tools, the BBC will
support the Partnership’s mission of advancing cancer equity among underserved and underrepresented
racial/ethnic minority populations, while breaking systemic barriers that under-represented minorities (URM)
encounter in the research workforce through research training, support and infrastructure that helps enable the
careers of URM investigators and trainees.